PATHOLOGY OF AGING

We have initiated collection and storage of specimens to evaluate changes in ovarian morphology, serum estrogen, bone density and DNA deletions over time in female rhesus monkeys. The results should provide a basis for study of aging females from puberty through menopause.